Human Tissue Repository and Tissue Analysis

Project Summary/Abstract - Human Tissue Repository & Tissue Analysis Shared Resource
The UNMCCC Human Tissue Repository and Tissue Analysis Shared Resource (HTR Tissue), supports basic
and translational cancer research by providing cost effective tumor and matched normal tissue either as frozen
or Formalin-Fixed, Paraffin-Embedded (FFPE) aliquots to UNMCCC members and non-member users. Scientific
Director Dennis J. McCance, Ph.D. (CT) supervises the Resource, which is operated by a full-time staff
including experienced wet lab research technicians plus a digital imaging expert providing services aligned with
the College of American Pathologist (CAP) Accreditation Program. The UNMCCC and the UNM HSC
Department of Pathology jointly manage the Resource, which provides several essential services including
sectioning, H&E, immunohistochemical or immunofluorescence staining of tissue sections and digital imaging
and annotation of stained specimens. The Resource currently houses > 40,000 biospecimens, with >20,000
frozen and >13,000 FFPE biospecimens and >6,000 blood samples (whole blood, serum, plasma and both
frozen and cryo-preserved cells) that reflect the race/ethnicity of our population in New Mexico with 36% of the
samples from Hispanic, 49% from non-Hispanic white and 12% from Native American and 3% other
race/ethnicities. During the last grant period we dispensed 1,196 tissue specimens, 1,496 slides for DNA/RNA
extraction and processed 4,000 animal tissues. As the Cancer Center has developed its precision medicine
initiative and joined the ORIEN consortium, HTR Tissue has expanded the tissue collection to include blood
and/or saliva from all consented patients (germline control), and blood and bone marrow from patients with
hematological malignancies (New Services). The Resource maintains a database of the collected tissues
(TissueMetrix) with critical information on the patient (e.g. name, date of birth and race/ethnicity), tissue source
and diagnosis, and other variables including the method of tissue collection, ischemic times, and how the tissue
was processed after receipt by the HTR Tissue. Projects, billing and usage are tracked through a centralized on line system. The Resource Director and staff work closely with the Research Programs to develop new
methodologies that promote innovative basic and translational research goals and the Resource actively
facilitates and disseminates information about new imaging and annotation technologies by maintaining an up to-date web page and by giving presentations at UNMCCC meetings and retreats. During the previous 5-year
project period, 101 investigators, of whom 59 were UNMCCC members from all 3 UNMCCC Research Programs,
used the Resource. The Resource contributed to 38 cancer focused publications by the UNMCCC users, who
were supported by 120 peer-reviewed grants. In the reporting year of July 2019 – June 2020, the CCSG
supported 17% of the Resource budget with UNMCCC members responsible for 74% of Resource usage.